Engineering T cells to overcome inhibitory receptor signals that limit the efficacy of adoptive cell therapy against ovarian cancer

PROJECT SUMMARY
Over 20,000 women are diagnosed with ovarian cancer in the United States annually, and over half will die
within five years. Outcomes have changed little in the last 20 years, highlighting the need for more effective
therapies. One promising new strategy employs immune T cells engineered to target proteins uniquely
overexpressed in tumors; such T cell immunotherapies have the potential to control tumor growth without
toxicity to healthy tissues. My ongoing work targets the antigen mesothelin (Msln), which contributes to
malignancy and invasive progression in ovarian cancer but has limited expression in healthy cells. I showed
that T cells engineered to express a human or mouse Msln-specific high-affinity T cell receptor (TCRMsln) can
kill human ovarian cancer cell lines or the murine ID8 cell line, respectively. In a disseminated ID8 tumor
model, adoptively transferred TCRMsln T cells preferentially accumulated within established tumors, delayed
ovarian tumor growth and significantly prolonged mouse survival. However, data also revealed that the ovarian
tumor microenvironment (TME) limits engineered T cell persistence and anti-cancer efficacy.
Tumor-specific T cells express inhibitory receptors upon encountering antigen, reducing antitumor cytokine
production. I detected the ligands for the PD-1, Tim-3 and Lag-3 inhibitory receptors (immune checkpoints)
expressed in human and ID8 ovarian tumors. Moreover, tumor-infiltrating TCRMsln T cells expressed PD-1, Tim-
3 and Lag-3, which correlated with reduced cytokine production. I hypothesized that immune checkpoint
blockade could overcome inhibitory receptor ligation-driven suppression of engineered T cells. Therefore, I
treated tumor-bearing mice with TCRMsln T cells plus anti-PD-1, anti-Tim-3 and/or anti-Lag-3 checkpoint-
blocking antibodies, targeting up to three inhibitory receptors simultaneously. Triple checkpoint blockade
dramatically increased anti-tumor cytokine production by intratumoral TCRMsln T cells, but treatment also
produced greater off-tumor toxicities.
I now propose to use preclinical mouse models (Aim 1) and a novel human slice culture system (Aim 2) to
interrogate the transcriptomic and functional changes that occur in engineered T cells and the ovarian TME
after checkpoint blockade. I plan to use T cell engineering to knock down endogenous inhibitory receptor
expression in tumor-specific T cells and determine if anti-tumor function is improved without the immune-
related toxicities observed with systemic combination checkpoint blockade. Many solid tumors overexpress
Msln and share the same T cell inhibitory pathways. Therefore, the findings from these new studies will likely
inform the development of clinically-relevant T cell engineering strategies that are more resistant to immune
suppression within the solid TME of many malignancies.

Public health relevance
Project Narrative Engineered T cell therapy can effectively kill ovarian cancer cells, but there are still tumor-driven hurdles that T cells must overcome to truly beat ovarian cancer. The goals of the proposed research are to understand precisely how these tumors can block killing by T cells and to develop rational strategies to enhance cancer- killing without causing adverse side effects. Many solid tumors escape T cell therapy using the same obstacles that ovarian cancer employs, so our findings will likely help improve immunotherapies against multiple cancer types.